Research 1-Hogeveen

PROJECT SUMMARY
The overarching goals of the current CoBRE mentored PI project are to better understand, and precisely
modulate, the neurocomputational mechanisms underlying apathy in patients with chronic moderate-to-severe
traumatic brain injury (msTBI). Previous studies have established that apathy–characterized by a loss of
motivation–is a common and debilitating symptom of msTBI, but the underlying neural pathologies causing
apathy in msTBI remain unknown. Clinically, existing treatments for apathy in msTBI have limited efficacy,
either due to their reliance on high-level cognitive abilities that are often impaired in msTBI (e.g. cognitive
behavioral therapy), or their potential to induce unwanted and deleterious side effects due to a lack of circuit-
specificity (e.g. pharmacotherapies that modulate dopaminergic tone throughout the brain). Therefore, there
are significant needs for i) rigorous experimental neuroscience studies on the specific motivated behavior
circuits that–when damaged–cause apathy in msTBI, and ii) the development of circuit-specific approaches for
modulating motivation circuits in apathetic patients, not reliant on high-level cognitive functioning. In this
project, the PI will use task-based functional magnetic resonance imaging (fMRI) to determine whether apathy
in msTBI is associated with damage to the functional neural circuits involved in computing the anticipated
reward value of stimuli in the environment (i.e., stimulus valuation), and/or damage to the circuits involved in
determining whether a given reward is worth the effort required to obtain it (i.e., willingness-to-engage effort).
Additionally, the PI will leverage the insights derived from this msTBI project to determine whether task fMRI-
guided repetitive transcranial magnetic stimulation (rTMS) is a viable approach for circuit-specific modulation of
value and effort circuits. By establishing the effectiveness of fMRI-guided rTMS for selectively engaging value
and effort computation circuits, this project will form the bedrock for future R01 projects refining personalized
rTMS approaches for treating neurological and psychiatric patients experiencing a loss of motivation.
The PI’s goal is to build a world-class human neuroscience laboratory that develops innovative methods for
characterizing and stimulating the neural circuits underlying aberrant motivated behavior through independent
R01 funding. The current mentored PI project provides an ideal opportunity for the PI to jump-start this
research program. The senior mentors Drs. Mayer and Pirio Richardson have proven track records with NIH
funding and extensive experience using fMRI to elucidate the functional deficits caused by TBI (Dr. Mayer) and
using rTMS as a treatment for neurological patients (Dr. Pirio Richardson). Additionally, two leading scientists
(Drs. Husain, Claus, and Costa) who conduct state-of-the-art research on the neurocomputational bases of
motivated behavior and its pathologies have committed to consult on the proposed project. Therefore, the
mentoring team will be well-suited to guide the PI as he leads this project, and will facilitate his transition to
becoming an independent R01-funded investigator.

Public health relevance
PROJECT NARRATIVE Understanding the mechanisms underlying ‘apathy’–i.e., reduced motivation to perform goal-directed behaviors–in patients with moderate-to-severe traumatic brain injury (msTBI) has numerous potential health benefits, considering that loss of motivation is a common and impairing feature of a variety of brain disorders. The proposed research will investigate whether the brain mechanisms damaged in apathetic msTBI patients suggest an impaired ability to determine reward value (“is it good enough to pursue?”), diminished willingness- to-engage effort (“is it worth the effort required?”), or both. Finally, a component of the project will be devoted to developing and validating a precise approach for targeting these mechanisms through noninvasive brain stimulation, which could lead to a personalized medicine approach for treating apathy.